SCH: INT: Collaborative Research: Context-Adaptive Multimodal Informatics for Psychiatric Discharge Planning

Which psychiatric symptoms and behaviors are the most important to assess and manage during critical
points in psychiatric healthcare, such as the time leading up to hospital discharge? At present, psychiatry
lacks objective tests that could inform this and other clinically challenging–and potentially costly–
decisions. Establishing valid objective markers of psychiatric disease processes is especially challenging
compared with the development of biomarkers in other 5elds. One key challenge is lack of available data
from psychiatrically ill patients during key periods in their care trajectory, which the present project seeks
to address. A second major challenge, also addressed as a core feature in this project, is the complex,
context-dependence of human behavioral expression, which greatly complicates efforts to establish
robust, objective measures that re6ect underlying mental health disease processes. This project will
address both barriers, introducing a new computational framework, named Context-Adaptive Multimodal
Informatics, to identify and evaluate behavioral biomarkers related to discharge-readiness and
symptoms in severe mental illness. The project aims to address 5ve fundamental research challenges:
(1) Acquire a multimodal psychiatric discharge-planning dataset of 400 inpatients with severe mental
illness; (2) Create self-aware linear and neural models to identify multimodal behavioral biomarkers; (3)
Develop context-sensitive linear and neural models to contextualize behavioral biomarkers and quantify
the in6uence of context on behavior; (4) Build a new adaptive assessment planning framework which
creates a personalized patient analysis to rank contexts and modalities for the next assessment session;
(5) Assess the trustworthiness and generalizability of our measurements, models, and insights.
This research will improve basic understanding of social context and behavioral biomarkers, build
objective measures for mental health assessment, and more broadly, pave the way for a restructured
care-delivery system in which resources are allocated intelligently to ensure assessments are
informative with respect to desired clinical objectives.

Public health relevance
Charting mental illness trajectories to determine when, where, and how to intervene is a key objective of the NIMH mission to transform the understanding and treatment of mental illness. This project will: (1) deepen our understanding of the trajectory leading to hospitalization discharge with knowledge about behavioral biomarkers and their relationship to symptoms and discharge-readiness; (2) contribute to the knowledge on how social context impacts patient's behaviors since some symptoms or predictive biomarkers may only be seen in a specific context such as social or solitary interactions; and (3) contribute a credible, objective framework for behavioral measurement by defining interpretable biomarkers and latent factors for symptoms and discharge assessment. The project will also enable a judicious use of remote sensing and non-direct clinical encounters (e.g., telemedicine), which are increasingly viewed as essential capabilities in the medical fields to reduce costs while maintaining or elevating care standards.